Morphology Core

PROJECT SUMMARY
The Morphology Core’s objective is to increase the effectiveness of individual investigators to perform vision
research by providing the instruments and expertise required by: 1) providing equipment, training and support
needed for performing histological studies, ocular imaging and functional visual testing, plus the latest imaging
technology at a level exceeding the capabilities of any one individual laboratory; 2) promoting collaborations
and collegiality amongst basic and clinical vision scientists through the sharing of resources, techniques and
expertise; and 3) supporting all vision researchers including new faculty and both experienced and novice
users. To this end, we are fully equipped with state-of-the-art microscopes, ocular imaging and visual testing
instruments, plus microtomes, cryostats and histology tools. The Core is managed and operated by a highly
experienced manager, with specific expertise in tissue processing and immunostaining, as well as image
acquisition and interpreting services for histological evaluation.

Public health relevance
PROJECT NARRATIVE Morphology Core’s objective is to continue providing the instruments and expertise required by: and support needed for performing histological studies, ocular imaging and functional visual testing, plus the latest imaging technology at a level exceeding the capabilities of any one individual laboratory.